SNX-III ADMINISTERED TO PATIENTS WITH CHRONIC NON-MALIGNANT PAIN

Assess the safety and efficacy of increasing doses of SNX-111 administered intrathecally to patients with chronic, non-malignant pain.